TAS::75 0893::TAS SECURX: PREVENTING PRESCRIPTION DRUG DIVERSION IN SCHOOLS

In this Phase I SBIR project, KDHRC will create and evaluate SecuRx.com, a website to prevent prescription drug abuse in schools.